Bioengineering a cortical microtissue model to study human microglia in Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
Microglia are highly sensitive to the extrinsic cues from their microenvironment in a context-specific manner and
rapidly change around diverse cellular states via intrinsic transcriptional programs. The specific microglial state
that contributes to Alzheimer’s Disease (AD) pathology is still illy defined, mostly owing to the longstanding critical
need for a reliable and robust modeling tool. In light of the substantial difference between human and mouse
microglia, the iPSC-derived human microglia (iMG) have emerged as a rigorous platform to investigate
neuroinflammation and AD-linked genetics. A recent transition from 2D to 3D culture systems further enhances
the utility of iMG in understanding AD pathogenesis, but technical barriers remain. An improvement to achieve
better cellular diversity and functionality in a scalable 3D neural setting will make a desired tool that enables
precise monitoring and manipulations of iMG inside a stringently controlled brain-like milieu. Our long-term goal
is to understand the pathogenic determinants of neuroinflammation to inform crucial future treatment for AD, via
stem cell and engineering innovations. To this end, we propose here to introduce an original 3D culture platform
to examine the extrinsic and intrinsic elements of microglial activation in health and in AD, based on patient-
derived iMG grown in engineered primary rat cortical microtissues. Leveraging validated AD mutant iPSCs and
transgenic AD rats, our overall objectives are to 1) confirm the capability of our hybrid model to recapitulate
human-specific, AD-related microglia features and signature and 2) to characterize the ‘ground state’ and
neuroinflammatory responses of control and AD iMG under a physiological or pathological microenvironment
(i.e. wildtype vs. AD transgenic microtissue). Supported by our preliminary studies, our central hypothesis is that
the iMG-microtissue growth system supports maturation and operation of human microglia and can be utilized
to detect the nuances in microglial behaviors that may contribute to AD pathogenesis. Our specific aims are to
test our working hypotheses that 1) iMG populated in cortical microtissues mimic homeostatic human microglia
in vivo and can be phenotyped for microglia-intrinsic manifestations contributed by genotypes, and that 2) iMG
maintained in AD mutant microtissues are affected by the AD-promoting extrinsic cues and show disease-
associated characteristics. Our expected outcomes are to 1) establish a new-generation in vitro human microglia
model system that uniquely allows dissecting the intertwined influences from AD-linked genetics and
microenvironment on microglial functions and 2) to acquire a distinctive dataset that would offer a framework to
pinpoint critical microglia characteristics for AD. We believe an expansion of this research beyond this award
period to characterize in depth the microglial findings uncovered here will ultimately bring a valuable opportunity
for the development of much-needed intervention and prevention strategies for AD.

Public health relevance
PROJECT NARRATIVE This proposed research is relevant to public health because building a modeling tool to study human microglia in health and in disease not only greatly advance our knowledge on the glial contributions to AD pathogenesis but also present a proof of principle for forthcoming translational studies focusing on the neuroinflammatory mechanisms. Thus, this proposed research is relevant to the part of NIH’s mission that pertains to reducing the burdens of human disability.